BSR - SR Component

BIOSTATISTICS SHARED RESOURCE (BSR) – PROJECT SUMMARY
The mission of the Biostatistics Shared Resource (BSR) is to serve as a focal point for University of
Virginia Cancer Center (UVACC) Members to obtain professional assistance in the design, management,
analysis, interpretation, and reporting of their research studies. The primary objective of the BSR is to provide
high-quality statistical support essential for rigorous science and impactful cancer research. The BSR interacts
with Members across all Programs on new and on-going research initiatives. Key goals include a) proper study
design, data capture, and analyses to ensure scientific rigor and reproducibility; b) feasible accrual targets and
monitoring strategies; c) proper interpretations and presentation of research outcomes; d) development of
novel design strategies needed to address study-specific goals; e) collaboration with other Shared Resources
to aid and maximize research efforts and minimize duplication; and f) educating UVACC Members in proper
early-phase research design. BSR staff have many years of experience working collaboratively with clinical,
population, and laboratory scientists and possess a wide range of expertise in statistical methods that are
relevant to the research endeavors of the UVACC.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.